Administrative Core

ABSTRACT – ADMINISTRATIVE CORE
Centralized administration is critical for efficient program management, coordination, and execution. The
Administrative (Admin Core) will provide all logistical, scientific, managerial, financial, data management and
statistical support to facilitate and to coordinate the studies described in this P01 program. The Admin Core will
ensure that all the Projects and Cores function optimally and adhere to the timelines and milestones described
in this grant. The Admin Core will organize regular meetings, maintain regulatory approvals, provide fiscal and
logistic oversight, coordinate meetings and annual site visits with the External Advisory Committee (EAC) and
NIAID Program Officials to support this P01 program, liaise with HVTN clinical protocol teams, and provide
centralized data management and data analysis support for all preclinical studies for this program. This
detailed administration and management structure will ensure that all the studies function efficiently and remain
focused on the overall objective maximizing the opportunities to speed the initiation of a pediatric HIV vaccine
in humans.
To achieve these goals, the Administrative Core proposes the following Specific Aims: Aim 1: Provide overall
management and coordination of the program to foster collaboration, interactions, and scientific progress. Aim
2: Manage and execute data management, publication, and data sharing plans. Aim 3: Provide centralized
biostatistics support. Aim 4: Ensure compliance with all institutional, state, and federal legal, accounting, and
scientific guidelines.